The Role of Cell-Specific PD-L1 in cardiac pathophysiology post Ischemic Injury and Cancer

Project Summary
Immunotherapy, particularly immune checkpoint inhibitors (ICI), is a rapidly advancing cancer treatment. Despite
its high effectiveness, ICI pose the risk of immune-related adverse events (IRAEs), including potentially fatal
cardiotoxicities. Limited research into the underlying mechanisms of ICI-mediated cardiotoxicities emphasizes
the need for further investigation. Monoclonal antibodies targeting immune checkpoint inhibitors like programmed
death-1(PD-1), programmed death-ligand-1 (PD-L1), and cytotoxic T lymphocyte antigen-4 (CTLA-4) have
gained prominence in cancer treatment. PD-L1 is abundantly expressed in cardiac tissue across major cell types
including fibroblasts (FB) and myeloid cells. FB activation, fibrosis, and inflammation are central to ischemic
cardiac injury, repair, and remodeling. Cross-talk between fibroblasts and immune cells is crucial for healing and
remodeling the ischemic heart. Indeed, significant upregulation of PD-L1 was observed in fibroblasts (FBs) and
myeloid cells within the ischemic hearts during heart injury. Employing fibroblast-specific PD-L1 KOs, our
preliminary data indicate FB-PD-L1's role in driving cardiac inflammation and adverse remodeling post-MI. Pilot
data on myeloid cell-specific PD-L1 KOs suggest that deleting PD-L1 in myeloid lineage promotes myocardial
inflammation and leads to cardiac dysfunction and adverse remodeling. The preliminary data strongly support
our overall hypothesis that FB-PD-L1 / Myeloid-PD-L1 is a critical regulator of the repair and remodeling of the
infarcted heart. However, the specific role of each cell type in the PD-L1 signaling axis-mediated autoimmune
cardiac disease pathology remains unclear. Furthermore, our preliminary results demonstrate that myeloid-PD-
L1 may regulate the repair and remodeling of the ischemic heart by regulating the recruitment of pro-inflammatory
CCR2+ macrophages and promoting Th17 cell polarization. Our studies will specifically aim to unravel the
detailed mechanisms underlying cardiotoxicity and tumor efficacy mediated by fibroblast (FB) and myeloid-
specific PD-L1 in syngeneic colorectal cancer models (MC38). Recognizing the dual roles of CCR2+
macrophages and Th17 in both promoting tumorigenesis and contributing to cardiac remodeling, we also
propose interventions targeting CCR2+ macrophages and Th17 cells to preserve cardiac pathophysiology while
maintaining antitumor efficacy during PD-L1 inhibition in myeloid cells. Thus the development of innovative
strategies to mitigate cardiotoxicity induced by cancer therapeutics holds substantial promise for public health.

Public health relevance
Project Narrative: Immunotherapy, particularly PD-1/PD-L1 blockers, is a highly effective cancer treatment, but it carries the risk of rare but potentially fatal cardiotoxicities. The limited understanding of these cardiotoxicities underscores the need for novel strategies to manage them, presenting significant public health implications. The proposed work is of high significance as it addresses challenging cardiac problems in immunotherapy (PD-L1-based) cancer patients lacking specific treatments.